Predicting neoadjuvant treatment response of locally advanced rectal cancer using co-registered endo-rectal photoacoustic and ultrasound imaging

In 2020, rectal cancer caused over 339,000 deaths globally, and 732,000 new cases were reported. Historically,
Stage II and III tumors, also known as locally advanced rectal cancers (LARC), have been treated with surgical
resection, radiation, and chemotherapy. However, advances in neoadjuvant (preoperative) treatment now enable
up to 35% of patients to achieve complete tumor death, or complete response, with radiation and chemotherapy
alone. In these individuals, surgical resection has shown no benefit and carries the significant risks of major
complications, prolonged recovery, and reduced quality of life. Unfortunately, standard clinical testing and
radiographic and endoscopic imaging modalities poorly differentiate post-treatment scars from the residual
tumor. Confounded by post-treatment fibrotic reaction and edema, the poor performance of current technology
makes it extremely difficult to identify complete responders before surgery. Due to this technological gap,
surgical resection remains the standard of care (SOC) for all patients outside of specialized tertiary care centers.
With improved imaging modalities, widespread adoption of nonoperative management would reduce treatment
morbidity for thousands of rectal cancer patients annually. One promising modality, photoacoustic imaging, uses
hemoglobin as an endogenous contrast agent to map tissue vascular networks. For clinical use, we have
developed and tested a new co-registered acoustic resolution photoacoustic microscopy and ultrasound (AR-
PAM/US) endoscopy prototype system, together with a deep learning neural network classifier. Initial testing
demonstrated a unique marker of complete tumor response – specifically, recovery of normal mucosal vascular
architecture within the treated tumor bed. We hypothesize that our co-registered AR-PAM/US system and the
neural net classifiers can assist surgeons to examine the residual tumor microvessel network and assess rectal
cancer patients’ pathologic complete response after neoadjuvant treatment. We also hypothesize that serial AR-
PAM/US studies will perform significantly better than SOC methods in predicting complete response at treatment
conclusion and during post-treatment surveillance.
We propose to advance and optimize our prototype AR-PAM/US system, probe, and software and to optimize
AR-PAM neural network classifiers to accurately differentiate complete responders from those with residual
cancer. We will prospectively assess the ability of co-registered AR-PAM/US technology to improve SOC
imaging in a cohort of LARC patients on post-treatment risk management and surgery recommendation. We will
also monitor a group of LARC patients to determine if the co-registered AR-PAM/US technology can assess
changes in tumor vascular and blood oxygen saturation and identify rectal cancer response, both during the
course of treatment as well as in post-treatment surveillance. If successful, this technology will directly reduce
the number of unnecessary surgeries for rectal cancer and improve quality of life.

Public health relevance
This study will advance and optimize a co-registered photoacoustic microscopy and ultrasound endoscopic system to fill a critical gap in the current management of rectal cancer: identifying tumor treatment response after neoadjuvant therapy. A clinical trial will evaluate the system’s ability to identify treatment responders and therefore reduce morbidity in the treatment of this common disease. Finally, serial surveillance of patients with complete responses to therapy will investigate markers of tumor recurrence among this high risk population.